Understanding the structural, functional, and prognostic implications of cortical excitability in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is the leading cause of dementia and is increasing worldwide, yet currently
lacks effective disease-modifying treatments. One possible missing link is a failure to restore normal neuronal
function. Measures of cortical excitability using transcranial magnetic stimulation with electroencephalography
(TMS-EEG) have the potential to fill this gap by measuring the neuronal response to controlled perturbation.
The long-term goal of this project is to determine the extent to which cortical excitability is an important
prognostic marker and/or treatment target in AD. This study assesses excitability in both motor cortex—a well-
characterized TMS site—and parietal cortex—a brain involved in the early stages of AD pathogenesis in a
cohort of early-stage symptomatic AD participants (early AD). The hypothesis is that increased cortical
excitability in parietal cortex is related to neurodegeneration, decreased network connectivity, and more rapid
clinical decline. This will be tested with three independent Aims to assess how cortical excitability is related to
1) local cortical thickness, 2) resting state fMRI connectivity; and 3) disease progression. The proposed project
is highly innovative, using TMS-EEG measures to capture local cortical excitability in AD, integrating
neuroimaging and neurophysiologic measurements, and testing the extent to which cortical excitability predicts
meaningful clinical outcomes. This contribution will be significant because it will inform our understanding of
how measures of synaptic function are related to disease progression in AD. This study will lay the groundwork
for future clinical trials in AD seeking to measure restoration of neuronal function using novel biomarkers.
The candidate has a strong commitment to a clinical research career in Alzheimer’s disease and related
dementias and an excellent mentorship team including Dr. Press, Dr. Fox, Dr. Shafi, and Dr. Sperling. Her
funded 5-year K23 project supports her career development by building expertise in AD biomarkers, advanced
neuroimaging techniques, and biostatistics. However, in the first year of her K23 the candidate experienced the
birth of her first child on 10/25/2021 and took a 3-month leave of absence. The applicant received an initial
Supplement that allowed her to return to full productivity by supporting participant recruitment and initial data
analysis. The applicant is now expecting the birth of her second child on 10/07/2024 during Year 4 of her K23,
and will take another 3-month leave of absence. A second Continuity and Retention Supplement is now being
requested to offset newly increased family responsibilities. This Supplement will speed up data analysis and
manuscript submission and allow for collection of longitudinal TMS-EEG data to support the applicant’s
upcoming R01. This Supplement will allow the applicant to return to full productivity and successfully submit
her first R01 in the next year, and will be integral to her career development as she launches a career as an
independent investigator using novel neurophysiologic tools to advance treatment of AD.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is the most common cause of dementia in the United States, but recent drug trials have failed to show an improvement in cognitive outcomes. Cortical excitability (measured using noninvasive brain stimulation) has the potential to serve as a novel prognostic marker or treatment target, and is relevant to public health due to its potential future applications in Alzheimer’s disease clinical trials. This is directly relevant to the NIH’s mission of advancing the diagnosis, prevention, and cure of human diseases.